Private Equity Expansion in Assisted Living: Implications for Dementia Care

PROJECT SUMMARY
Assisted living (AL) is a growing long-term care industry providing housing and supportive services to
800,000+ frail and functionally impaired older adults - over 40% of whom are living with Alzheimer's disease or
a related dementia (ADRD). Demographic projections of increased demand for AL, and especially dementia
care (also referred to as “memory care”), has attracted notice from private equity (PE) firms. PE ownership
advocates argue that PE firms bring much needed capital, allowing providers to update facilities, invest in new
technology, and gain economies of scale to enhance efficiency, increase profitability, and improve care quality.
However, the growing concern is that some PE firms' focus on short-term profits may compromise the quality
of care of AL residents, particularly those living with dementia. Research findings on the effects of PE
acquisitions of nursing homes are mixed: while some studies found negative effects (e.g., decreased staffing,
increased mortality) others have found no change in staffing or quality outcomes. However, unlike nursing
homes, AL is most often paid for privately; and, there is no national framework of regulations, payment policies,
or public reporting of care quality to work as “guardrails” against the possible negative impacts of PE
acquisitions as there are in nursing homes. Therefore, the objective of this application is to understand the
types of AL that PE firms invest in and how PE acquisitions impact the composition of residents with ADRD
and residents' outcomes. Our working hypotheses are: 1) ALs that are part of a large chain, located in markets
with more demand, and operating under licenses with less regulatory stringency are more likely to be
purchased by PE firms; and 2) acquired ALs respond to changes in ownership by restructuring operations in
ways that influence the composition of residents and ultimately residents' outcomes. These hypotheses will be
tested in an exploratory/explanatory sequential mixed methods study with three specific aims: 1) Explore
stakeholders' perceptions of PE firms' motives and the impact of PE investment on AL communities; 2)
Compare ALs that were acquired or divested by PE firms between 2010 and 2019 to those that were not; 3)
Estimate the causal effect of PE acquisitions on the prevalence of residents with ADRD in AL and residents'
outcomes over a 10-year period. Under the first aim, the research team will leverage their existing networks
and interview stakeholders to elicit different perspectives on the motives and impacts of PE acquisitions. Under
the second aim, the team will apply the methods they developed and data they previously collected to
understand which ALs are PE targets. The third aim will examine the welfare effects of PE acquisition on
residents with and without ADRD applying an instrumental variable method. The results from this study will be
the first to investigate PE acquisitions of AL. As policymakers are urged to consider ownership reporting and
monitoring in other sectors, it is important to have insight into the less regulated AL industry that provides
supportive services to vulnerable older and disabled adults, almost half of whom are living with dementia.

Public health relevance
PROJECT NARRATIVE This research will provide critical information about private equity firms' acquisitions of assisted living, and the impact of these acquisitions on older adults needing long-term care in these settings, including the growing population with Alzheimer's disease-related dementias (ADRD). This research is aligned with NIA's goal to improve the health and well-being of older people and will accelerate progress on meeting Goal 2 of the National Plan to Address Alzheimer's Disease to "enhance care quality and efficiency" for people with ADRD.